Tissue Engineering Resource Center

SUMMARY
Tissue engineering is rapidly developing, but remains limited by (i) scaffold and bioreactor designs that are based
on predetermined parameters, and (ii) the lack of real-time, nondestructive measurements of cell and tissue
function. To overcome these two limitations, we will develop adaptive-responsive biomaterials that can sense
environmental signals and actuate the cells, and imaging-enabled bioreactors with real-time spatiotemporal
control of engineered tissues with feedback from the measured cell responses. Our goal is to offer these
advances to the tissue engineering community and translate them into clinics. The proposed renewal of the
Tissue Engineering Resource Center (TERC) brings together a highly productive interdisciplinary team of
actively collaborating investigators from Columbia University (lead institution), Tufts University, Columbia
University Irving Medical Center and Stevens Institute of Technology. An Administrative Board will coordinate
the Center’s activities, with the oversight and guidance of an exceptionally strong External Advisory Committee,
formed from the world leaders in tissue engineering and clinical translation. TERC will partner with a number of
existing resources (please see 18 letters of support), and will benefit from the exceptional resources provided by
our institutions and the very generous financial support of the Columbia University School of Engineering
($2,125,000 over the five-year cycle). The technical components of the Center are three Technology Research
and Development Projects (TR&D1: Adaptive-responsive biomaterials; TR&D2: Imaging enabled bioreactors;
TR&D3: Translational technologies), 17 Collaborative Projects, and 16 Service Projects. We also propose a
robust and highly diverse Technology, Training, and Dissemination program for biomedical investigators to
facilitate the use of new technologies and raise awareness about TERC, and comprehensive Outreach to
students, the general public, underrepresented and underserved communities. With a highly innovative scientific
premise, extensive foundational research, strong leadership and institutional support, experience in translational
research, and long history of collaboration among the lead investigators, we are confident that the Center will
accomplish its mission of serving as a transformative driving force in the field of tissue engineering.

Public health relevance
PROJECT NARRATIVE The mission of the Tissue Engineering Resource Center is to transform the field of tissue engineering and its therapeutic applications by developing next-generation technologies for engineering human tissues. We anticipate that the Center will enable transformative modalities in regenerative medicine and the treatment of diseases, while also providing collaborations, service, training, dissemination, and outreach to both the tissue engineering community and the general public.